NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens

Project Summary/Abstract
The Connecticut Department of Public Health (CT DPH) State Public Health Laboratory (SPHL) is currently
participating in the National Antimicrobial Resistance Monitoring System (NARMS) retail meat program
through the Food and Drug Administration/Center for Veterinary Medicine (FDA/CVM). The purpose of
this surveillance is to monitor the prevalence and trends of antimicrobial resistance in Salmonella,
Campylobacter; Enterococcus, Escherichia coli, Vibrio, and Aeromonas isolated from retail food samples
purchased from grocery stores in the United States. This surveillance project is intended to improve the
detection of antibiotic resistance among bacteria in food commodities. This application will seek funding
to support the CT DPH SPHL’s continued participation in the NARMS antibiotic resistance surveillance of
retail food samples. The requested funding will support one full-time employee (FTE) who will be
responsible for surveillance activities. Specific duties of this position include: (a) purchasing 23 retail food
samples from randomly selected grocery stores throughout Connecticut each month, samples include 4
chickens (bone-in/skin-on), 6 ground turkey, 4 ground beef, 1 chicken liver, 1 chicken heart and 1 gizzard,
2 salmon, 2 tilapia, and 2 shrimp. (b) performing all phases of microbiological testing including initial
enrichments, secondary enrichments and culture testing for the identification of Salmonella,
Campylobacter, Escherichia coli and Enterococcus isolates from retail meat and poultry samples and initial
enrichments followed by culture testing for the isolation of Vibrio, Enterococcus, and Aeromonas from
seafood samples. All testing is performed following protocols provided by FDA/CVM (c) entering all
sample information and results into the electronic NARMS data sheets and the Laboratory Information
Management System (LIMS); (d) shipping all isolates monthly to FDA/CVM (e) submitting all required
NARMS electronic data sheets monthly (f) performing necessary quality assurance/quality control
functions; (g) submitting Salmonella, Campylobacter, and primary Escherichia coli isolates to the CT DPH
SPHL Advanced Molecular Detection (AMD) section for whole genome sequencing (WGS). (h) The CT DPH
SPHL AMD section submits sequences to NCBI and uploads to PulseNet monthly. Clusters of 2 or more
WGS-closely related isolates, clinical or clinical and food, (local or multistate involving CT) prompt same-
day notification from the CT DPH SPHL to CT epidemiologists to facilitate a rapid and complete
investigation. The CT DPH SPHL looks forward to participating in this program to provide data for the
improvement of the detection and surveillance of resistance among foodborne bacteria.

Public health relevance
Project Narrative The Connecticut Department of Public Health State Public Health Laboratory (CT DPH SPHL) is currently participating in the National Antimicrobial Resistance Monitoring System Retail Meat Surveillance. The purpose of this surveillance is to protect and promote public health by enhancing, strengthening and sustaining antibiotic resistance surveillance in retail food samples. The primary bacteria under surveillance include Salmonella, Campylobacter, Escherichia coli, Enterococcus, Vibrio, and Aeromonas isolated from retail food samples purchased from grocery stores in the United States. This surveillance project is intended to improve the detection of antibiotic resistance among bacteria in food commodities. Data from this project will contribute to improving the detection and surveillance of resistance among foodborne bacteria. It also will promote interventions to reduce drug resistance by determining limitations for antibiotic use in veterinary medicine and by assisting in the development of pre-approval safety evaluation for new animal antibiotics.